Polymicrobial interactions in Crohn's Disease

The role of gut fungal community (“mycobiome”, MYC) and interactions between the bacteriome (BM) and fungal
communities in Crohn’s Disease (CD) have been relatively ignored. Recently, we compared the gut BM and MYC
of CD patient’s to their healthy relatives and showed that abundance of the fungus Candida tropicalis (CT) was
positively correlated with the bacteria Serratia marcescens (SM) and Escherichia coli (EC).
We analyzed the
number of CD patients that had all 3 species; the number CD patients exhibiting all 3 organisms was 30%,
compared to 9% in healthy controls. Critically, abundance of all three organisms is 6.2 fold higher in CD patients
vs. controls. Thus, the prevalence of this combination of microorganisms in the GI tracts of CD patients is significant.
We further showed that ex-vivo, these polymicrobial triple species cooperated to form robust biofilms (TSBs) that
were significantly increased compared to those formed by single-species (SSBs) or double-species (CT+EC or
CT+SM, DSBs). Supporting data showed the interaction between CT, SM, and EC was specific; substitution of
Trichosporon spp. (TC) or Saccharomyces fibuligera (SF) did not increase biofilm formation. However, preliminary
data using Candida albicans (CA) as a control comparator reported by others to be elevated in CD patients, did
cause increased TSB biofilm formation, indicating that this is a Candida specific effect. Importantly, we validated
that the 3 pathogens formed robust biofilms in vivo (an anaerobic environment) using a dextran sodium
sulfate (DSS) model of murine ulcerative colitis. Metabolomic analyses of supernatants from TSBs identified 11
significantly increased metabolites compared to SSBs or DSBs. Of these, 5-oxoproline (5-OP), was the most
elevated metabolite (131-fold higher in TSBs compared to SSBs or DSBs). Also, Indole-3-acetic acid (IAA), formed
as a result of Lactobacilli metabolizing tryptophan, which can act as an endogenous ligand for aryl hydrocarbon
receptors (AhR), mediating innate lymphoid cell (ILC) production of IL-22, that in-turn triggers the inhibition of CA
colonization, was also significantly increased. These 2 metabolites influence candidal virulence factors
(filamentation, adhesion and auto-aggregation). Although these data are significant and indicate a strong
polymicrobial interaction in CD, they do not establish the underlying mechanisms of these microbial interactions.
This proposal focuses on determining the mechanism/s underlying the interaction of mixed species microbes using
complementary in vitro and in vivo approaches.
Our hypothesis is that SM, EC and Candida (CT and CA), in the
setting of biofilms, interact cooperatively to exacerbate intestinal inflammation and exacerbate symptoms
To address the mechanism(s) we will: (1) Determine the mechanism(s)
metabolites formed by CT, EC, and SM in TSBs alter intestinal outcomes; (2) Identify gene changes
underlying Candida modifications that increase pathogenicity using microbial mutant strains and RNAseq
approaches; and (3) Determine whether exposure of TSBs to antibacterial, antifungal or metabolite
inhibitors modulates the severity of intestinal inflammation in vivo.
via multispecies interactions.

Public health relevance
The current application is designed to gain insight into the mechanism(s) of bacterial/fungal polymicrobial interactions in the setting of intestinal inflammation, similar to that observed in inflammatory bowel diseases such as colitis and Crohn’s. Specifically, we propose to examine how metabolites produced as a result of this interaction may exacerbate pathogenicity. In addition, we will localize the metabolites in the intestinal mucosae and stool using in vivo imaging, and quantify them using MALDI MS/MS approaches. Alternatively, substituting mutant non- pathogenic organisms will determine genes implicated in increased inflammation associated with mixed species infection. Moreover, we will determine whether interrupting mixed species biofilm formation using antibacterial, antifungal or metabolite inhibitors reduce the observed pathogenicity and inflammation associated with polymicrobial infection.